Global Methods for Characterizing and Discovering New Protein Kinase Regulatory Mechanisms

Project Abstract
Perturbations to cellular phosphorylation levels are highly correlated with a variety of disease states. Because
protein kinases are the enzymes responsible for protein phosphorylation, they play a central role in maintaining
homeostatic phosphorylation levels, and as such have become attractive drug targets. Consequently, the
regulatory mechanisms that govern protein kinase activity have been studied for decades. Roughly half of protein
kinases have at least one protein domain in addition to their catalytic kinase domain4 and in many cases these
domains serve as “regulatory domains” by making physical contacts with surfaces on the catalytic domain,
disrupting the alignment of catalytically necessary residues. While the intramolecular regulatory mechanisms of
many kinases have been delineated, there are many layers of regulation that lack definition. Specifically, a
collaborative effort between the Maly and Fowler labs revealed new putative regulatory surfaces on the catalytic
domain of the long-studied Src kinase. One central hypothesis of this proposal is that there are similar but distinct
regulatory surfaces on other members of Src Family of Kinases (SFKs) which give rise to differences in kinase
substrate specificity, localization, and overall mechanisms of regulation. Given the involvement of the SFKs Lck
and Fyn in T-cell development and mature thymocyte signaling, we would like to better understand how these
regulatory surfaces contribute to productive T cell receptor (TCR) signaling, which has yet to be systematically
explored. Therefore, the experiments in Aim 1 will identify putative inter- and intramolecular regulatory surfaces
on Lck—the most centrally involved SFK in TCR signaling—and between Lck and two members of the TCR
complex (CD45 and Csk) using a series of saturation mutagenesis Deep Mutational Scans (DMS) in yeast.
Experiments in Aim 2 will leverage the DMS dataset obtained in Aim 1 as the foundation for implementing the
recently published Parallel Chemoselective Profiling method25 for characterizing the dynamic protein features of
Lck in solution. This method will also facilitate the functional characterization of the putative regulatory surfaces
discovered in Aim 1. Finally, experiments in Aim 3 will explore the phosphotransferase dependent and
independent functions of both Lck and Fyn in the context of T cell activation using a new chemoproteomic
technology3. In addition to revealing fundamental information about the roles of Lck and Fyn in mediating healthy
TCR signaling, the methods described herein are general, and can be applied to study any protein of interest.

Public health relevance
Project Narrative The Src Family of Kinases (SFKs) are multi-domain protein kinases that are involved in diverse and complex cellular signaling cascades including T Cell Receptor signal transduction—a necessary component of a healthy immune system. Specifically, the SFKs Lck and Fyn are known to use their kinase and regulatory protein domains to phosphorylate or scaffold various interactions required for proper T Cell activation; however, many questions remain about the phosphotransferase dependent and independent functions of each kinase. These challenges are addressed by this proposal which describes the development and implementation of general Deep Mutational Scanning (DMS) and chemoproteomic methods which will then be used to biochemically characterize structural features and protein-protein interfaces on Lck, and identify the distinct conformation- dependent interactors of Lck and Fyn during T Cell activation.